Hyper-surveillance and suicides among Black youth in the U.S.

PROJECT SUMMARY
Suicide rates among Black youth have increased significantly in recent decades, exceeding those among Whites
by over 60%. Black youth also surpass all other racial/ethnic groups in Emergency Department (ED) visits for
suicidal ideation/self-harm. Scholars have suggested that racism and discrimination may be potential causes of
these concerning trends. One visible and pervasive example of routine discrimination against Black populations
is hyper-surveillance through racially targeted police stops. Research shows that police contact is a social
determinant of mental health among youth, with an increase in psychological distress, anxiety, depression, and
trauma symptoms following police contact. However, no study has examined the causal relationship between
racially disproportionate police stops and ED visits for suicidal ideation/self-harm and suicide mortality among
Black youth. To address this gap in research, we propose to examine the relation between police stops and (i)
ED visits for suicidal ideation/self-harm and (ii) suicide mortality among Black youth (outcomes). We propose a
multi-state, county-level examination of the relation between police stops of Black individuals and suicide-related
outcomes (ED visits for suicidal ideation/self-harm, suicides) across 10 US states (AZ, FL, KS, MA, MN, NC, NJ,
NY, SC, WI), from 2006 to 2019 using national, high quality datasets and advanced econometric methods. We
also leverage the unique case of the New York Police Department's (NYPD) stop, question, and frisk (SQF)
policy as a natural experiment towards causal examination of the relation between racially targeted police stops
and suicide-related outcomes among Black youth in New York City (NYC). In 2013, a federal court ruled NYPD’s
SQF policy unconstitutional (Floyd, et al. v. City of New York, et al., 2013), and the number of stop-and-frisks
conducted by NYPD declined sharply. We will use this ruling as a natural experiment to examine the causal
impact of hyper-surveillance on suicides among Black youth in New York City. We will retrieve data on police
stops by race for 10 US states from the Stanford Open Policing Database, and New York City-specific police
stops data from the New York Civil Liberties Union's stop-and-frisk database. Suicide mortality by region, age,
race, and sex will be obtained from the National Center for Health Statistics mortality database. We will acquire
ED visits data (by ICD9/10 diagnosis code, race, age, sex, county, month, year) from the State Emergency
Department Database (SEDD) and the State Inpatient Database (SID). We will formulate our exposures as the
volume of police stops of black persons and the ratio of Black to White police stops (per 100,000 population).
We will conduct empirical analyses using (1) two-way fixed effects, (2) time series, (3) difference-in-difference,
and (4) synthetic control methods to examine the spatio-temporal relation between our outcomes and exposures.
Our study will rigorously examine the ecological relation between racially disproportionate police stops and
suicide-related outcomes among Black youth. Findings from our study may inform policy-relevant interventions
for suicide prevention among vulnerable populations.

Public health relevance
PROJECT NARRATIVE The proposed work tests whether racially targeted police stops correspond with suicide-related outcomes among Black youth in a longitudinal, ecological manner. Our project may assist in elucidating the extent to which there exists a causal link between racialized hyper-surveillance and suicide mortality in a highly vulnerable population.